Sodium Entry into Amiloride-Sensitive Epithelia

DESCRIPTION (provided by applicant): Sodium transporting epithelia, such as renal distal and collecyting tubules, function to control whole-body homeostasis. Epithelial sodium channels (ENaC) have been found in other sodium transportinmg epithelia, e.g., salivary glands, colon, bronchial and tracheal epithelia, as well as in many non-epithelial cells, like lymphocytes, neurons and astrocytes. Amiloride inhibition is a hallmark of these particular channels, regardless of the system in which they are found. Yet, when macroscopic and single channel properties are examined using the patch clamp technique, a myriad of biophysical characteristics emerge. The central hypothesis of this application is that the observed functional diversitiy of amiloride-sensitive sodium channels results, in part, from different combinations of subunits of the Degenerin(DEG)/ENaC superfamily of ion channels. There are three specific aims. In the first specific aim, we will detrermine the biochemical composition of an amiloride-sensitive cation channel found in epithelial cells that exhibit biophysical properties different from ENaC. We present preliminary data using RT-PCRprofiling showing that message for a variety of DEG/ENaC memebers are present in these cells. Thus, we will use these cells as ,model systems to determine the biochemical composition of this channel. In addition, we will employ surface biotinylation, surface chemiluminescence, co-immunoprecipitation analysis, and macromolecular assembly assays, to verify subunit interactions. We will also use ellular protein knockout approaches, (and MTS reagent susceptibility studies), to establish subunit interaction. The second specific aim is to: a.) determine the biophysical characteristics of hybrid ENaC/ASIC, b.) identify ENaC/ASIC interaction using MTS reagent susceptibility. The third specific aim will determine the high resolution crystal structure of ?ENaC. These results wil offer new insights into the nature and ultimately the regulation of amiloride-sensitive sodium channels, and the ways that these hybrid channels can be modulated by inserting or deleting specific subunits of this DEG/ENaC superfamily. Thus understanding the molecular basis for ENaC diversity will provide unique opportunities for therapeutic interventions in an ever-increasing plethora of EWNaC-related diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: Epithelial sodium channel (ENaC) proteins and acid-sensing ion channel (ASIC) proteins are distributed all over the human body, are responsible for maintaining the body's salt and water balance, and play a role in hypertension, cancer, learning, and many other normal and abnormal processes. Through modern techniques of molecular biology, biochemistry, cell biology, and electrophysiology, our study results will provide insight into the cellular mechanisms of these channels in native tissues, especially in renal epithelia. The relevance of this particular study extends to autosomal recessive polycystic kidney disease, which affects 1 in 20,000 babies in the United States. Program Director/Principal Investigator (Last, First, Middle Project Narrative Epithelial sodium channel (ENaC) proteins and acid-sensing ion channel (ASIC) proteins are distributed all over the human body, are responsible for maintaining the body's salt and water balance, and play a role in hypertension, cancer, learning, and many other normal and abnormal processes. Through modern techniques of molecular biology, biochemistry, cell biology, and electrophysiology, our study results will provide insight into the cellular mechanisms of these channels in native tissues, especially in renal epithelia. The relevance of this particular study extends to autosomal recessive polycystic kidney disease, which affects 1 in 20,000 babies in the United States. PHS 398/2590 (Rev. 11/07) Page Continuation Format Page __SpecificAimsTextDelimiter__ SPECIFIC AIMS The ever-expanding Degenerin/ENaC (Deg/ENaC; ENaC = epithelial Na+ channel) superfamily contains over 60 proteins having a similar topology; (15, 35, 36, 43, 58, 68, 72, 75, 100, 109, 110, 113, 114, 125, 126, 129, 130, 134, 136, 160, 162, 187, 201, 202, 204, 219). All family members are cation selective and are blocked by the diuretic amiloride and related drugs (15, 16, 72). The acid-sensitive Na+ channels (ASICs), comprise a second branch of the superfamily (71, 172). All four members of this branch co-assemble to form heteromeric channels, most are gated by extracellular protons, and all are involved in a wide variety of cellular responses ranging from nociception to mechanosensation (26, 170). The Deg/ENaC family of ion channels have well-defined characteristics; for example, classical αβγENaC, as found in the renal collecting duct, exhibits long openings and closings, has a single channel conductance of 4-8 pS, a PNa/PK > 10, and a sub- micromolar affinity for amiloride (109). In contrast, ASIC channels exhibit moderate cation selectivity (PNa/PK 3- 10), a single channel conductance of 4-20 pS, and amiloride sensitivity in the tens of micromoles (109, 131, 221). However, many other amiloride-sensitive cation conductances do not conform to either of these profiles (57, 159). They have been categorized into three main groups (159, 160): a) channels of moderate selectivity (PNa/PK between 5-10), and small conductance (< 10 pS), e.g., pulmonary epithelia; b) channels of moderate selectivity and large conductance (50-60 pS), e.g., bovine renal epithelia; and c) poorly selective channels (PNa/PK ~ 1) of medium conductance (20 pS), e.g., alveolar epithelia. Other examples also exist, e.g., in pulmonary epithelia, δENaC confers different conductance, selectivity, and amiloride affinity characteristics when combined with βγENaC (Appendix Paper 5: A.5). In brain endothelia, a sodium channel with nanomolar affinity for the amiloride analog phenamil, poor PNa/PK selectivity, and a single channel conductance of ~ 20 pS, has been identified (202). We have discovered a channel in glioma cells that expresses characteristics intermediate between those of "pure" ENaC and "pure" ASIC channels, i.e., a low affinity for amiloride, poor PNa/PK selectivity, and a single channel conductance of 20 pS. Our evidence suggests that this channel is composed of a mixture of ASIC and ENaC components (A.8), and therefore may represent the first instance of a native amiloride-sensitive Na+ channel that is an ENaC/ASIC heteromer. We have recently shown that ENaC and ASIC subunits co-associate and generate a unique current in a model CHO cell system (A.6). In this application we present preliminary evidence demonstrating that ASIC and ENaC subunits also co-exist in the collecting duct of a murine model of autosomal recessive polycystic kidney disease Tg737orpk (217), and that these cells express a constitutively active Na+ current with low amiloride sensitivity that is blocked by psalmotoxin. It is our central hypothesis that the functional diversity of amiloride-sensitive ion conductances may be due in part to differential combinations of Deg/ENaC subunits that may in turn lend itself to plasticity in channel function, regulation, and ultimately cellular response. There are three specific aims: 1. To test the hypothesis that novel combinations of ASIC and ENaC subunits give rise to atypical amiloride- sensitive Na channels 2. To test the hypothesis that cross-clade ASIC/ENaC channels have unique properties due to novel structure/function relationships within the channel heteromer. 3. To express, purify, crystallize and determine the structure of ¿rENaC.